Endoplasmic Reticulum Stress in the function of cancer associated fibroblasts in pancreatic cancer

ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is one of the most lethal cancers, with a dismal 5-year overall survival
of 13%. Among the reasons for such a poor outlook is the presence of a highly fibrotic and immunosuppressive
microenvironment, characterized by activation and expansion of fibroblasts and their extracellular matrix (ECM).
During PDAC development, cancer-associated fibroblasts (CAFs) produce large amounts of ECM, cytokines,
chemokines and growth factors, and despite their pivotal pro-tumor roles, the drivers of their activation and pro-
tumor functions are still unknown. Paradoxically, elimination of CAFs and their ECM is unfavorable to patients,
suggesting that modulation, rather than elimination, of pro-tumor CAFs, is an innovative and attractive approach
in developing PDAC therapies. CAFs are highly secretory cells, which increases the load of misfolded proteins
in the endoplasmic reticulum (ER). Accordingly, our preliminary data uncovered that CAFs, compared to normal
fibroblasts, are under ER stress, upregulating sensors (IRE1, PERK and ATF6) and downstream effectors of the
unfolded protein response. When blocking these pathways with chemical inhibitors, CAFs produced less
immunosuppressive cytokines compared to vehicle treated CAFs, which in turn, allowed CD8+ T cells to
proliferate more when cultured with ER stress-inhibited CAFs. Finally, in a preliminary orthotopic syngeneic
model, mice treated with the inhibitor of the ER stress effector XBP1 had smaller tumors and higher percentage
of CD8+ T cells compared to control mice. These results led us to hypothesize that ER stress promotes and
sustains CAF pro-tumor functions, catalyzing PDAC tumorigenesis. In an innovative approach, here we propose
to investigate the roles of ER stress in fibroblast activation and function in PDAC, dissecting the contributions of
the different ER stress arms for their pro-tumor functions. Our long-term goal is to uncover new targets that can
modulate PDAC microenvironment to sensitize tumors to therapies. Using state of the art in vitro 3D culture
system, bona-fide normal donor pancreata and patient PDAC tissue for spatial transcriptomics, and refined in
vivo animal models, we will focus on 1) dissecting the roles of ER stress on the pro-tumor functions of fibroblasts,
2) determine the spatial distribution and functional relevance of ER stress in donor normal and PDAC tissue, 3)
test if specific arms of ER stress in CAFs promotes tumorigenesis in vivo. This study will not only determine the
roles of ER stress in fibroblast functions in PDAC, but also provide new insights into CAF biology in PDAC by
providing a framework to link common functional programs of different subsets of cells in the TME that coevolve
during tumor progression.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is one of the most lethal cancers, and one major reason for this is the expansion of non-tumor cells called fibroblasts, that produce a dense network of structural and secreted materials that act as a biochemical and physical barrier to therapies, promoting tumor growth. Due to their overproduction of secreted materials, fibroblasts undergo cellular stress (namely endoplasmic reticulum stress), and it is the goal of this project to understand how this phenomenon leads to pro-tumor fibroblast functions, so we can inhibit them. Understanding how fibroblasts support tumor growth will be critical to develop improved treatments to increase patient survival.